Evaluating the safety, immunogenicity and efficacy of a robust attenuated Mtb vaccine in the setting of HIV co-infection

PROJECT SUMMARY/ABSTRACT.
Novel vaccination strategies are necessary to contain the TB pandemic, as the currently licensed anti-tubercular
vaccine, Bacille Calmette-Guerin (BCG), has limited and variable efficacy. Attenuated, live-replicating
Mycobacterium tuberculosis (Mtb) express the full complement of protective antigens absent in BCG. As a result,
these strains are most likely to induce long-lived immune responses towards a wider antigenic repertoire and
could generate durable protection. Rhesus macaques vaccinated with an isogenic Mtb mutant in the allele
encoding the stress-response master regular SigH (sigH) were protected from TB after infection with a lethal
dose of Mtb and characterized by the presence of inducible bronchus associated lymphoid tissue (iBALT) in the
lungs. Protection by sigH could be reversed by the depletion of iBALT. We have now validated the protection
against TB by mucosal vaccination with sigH in cynomolgus macaques, a second NHP species. Our results
show that sigH vaccination protects cynomolgus macaques from lethal TB by inducing T cell responses, T-B
cell cooperation and iBALT in the lungs. This leads to the induction of strong IFNG responses, which inhibits
Type I IFN signaling, conditions macrophages towards an IFNG-, rather than a Type I IFN-responsive phenotype,
resulting in almost complete protection in the airways and lung granulomas.
It is important however, to understand the safety, immunogenicity and efficacy of attenuated Mtb based vaccine
candidates, as i) concerns remain about whether the candidate will be safer than BCG in the
immunocompromised population and ii) whether Mtb/HIV co-infected individuals will be able to mount protective
T cell-based responses to this vaccine, resulting in protection. Our current proposal addresses this by directly
testing the hypothesis in the rhesus macaque model of Mtb/HIV co-infection. Additionally, we propose to develop
the sigH vaccine platform by testing the immunogenicity and efficacy of two unmarked double/triple knock out
mutants including sigH which we have generated. We contend that at the end of this proposal, we will be able
to move sigH based DKO/TKO strains into human clinical development as anti-TB vaccines.

Public health relevance
NARRATIVE. The currently approved vaccine against TB, Bacille Calmette-Guerin (BCG), has limited and variable efficacy, thus necessitating the development of new, effective vaccines against TB. A Mtb mutant (DsigH) completely protects two species of monkeys from TB, giving hope that a derivative of it could end TB in humans. We propose to assess if this vaccine platform can be safely used to generate immune responses in a model of TB/HIV co- infection and immune dysfunction, as well as further preclinically develop this vaccine.